Lectikines for Immunotherapy against Ovarian Cancer

SUMMARY
The goal of this project is to create a novel immunotherapeutic drug candidate against ovarian cancer (OVCA).
OVCA is the leading cause of death from gynecological malignancy in the United States, with poor survival rates
due to late diagnosis and chemo-resistant, fatal recurrent disease after the first-line debulking surgery and
chemotherapies. Immune checkpoint inhibitors have thus far failed to show a significant clinical benefit due to
highly immunosuppressive tumor microenvironment and poor infiltration of T cells. Thus, the development of
effective OVCA immunotherapy requires novel strategies. To address this problem, the proposed project will
create novel immunotherapeutic proteins based on Avaren lectin. It is a small, 14-kDa recombinant protein
engineered in the PI’s laboratory from a natural actinomycete lectin, which selectively recognizes a cluster of
high-mannose glycans that are prevalent on the surface of enveloped viruses and malignant cells. A fusion
protein consisting of Avaren lectin and human IgG1 Fc (AvFc) was previously shown to exhibit potent antiviral
and antitumor activities without toxicity in in vitro and in vivo animal models. Based on growing evidence
indicating that high-mannose overaccumulation also occurs on the surface of OVCA cells, we hypothesize that
Avaren lectin can be utilized in novel OVCA-targeting strategies. Our preliminary data show that AvFc efficiently
binds to OVCA but not to adjacent normal tissues. AvFc elicited potent antibody-dependent cell-mediated
cytotoxicity (ADCC) against OVCA cell lines. Furthermore, AvFc treatment exhibited moderate yet statistically
significant efficacy extending the survival of animals in a syngeneic, orthotopic murine OVCA model using the
ID8 cell line. Building on these data, in this project we will create immunostimulatory variants of Avaren lectin
that can transform OVCA into more immunologically hot tumors, thereby exhibiting potent immunotherapeutic
efficacy. Specifically, we will engineer translational fusion proteins consisting of Avaren lectin / AvFc and an
antitumor cytokine (“lectikines”). In Aim 1, we will generate lectikines by fusing a variant of IL-2 devoid of CD25
binding (IL-2v) or IL-15 to AvFc, which will be produced in Nicotiana benthamiana plants using a transient
overexpression system. After thorough purification, we will assess their molecular properties, OVCA cell-binding
affinity and cytokine functions in a battery of biochemical, biophysical and cell-based assays. In Aim 2, we will
evaluate the therapeutic effects of lectikines in comparison with AvFc in a murine ID8 OVCA model. Disease
progression will be monitored through abdomen circumference, body weight, and live animal bioluminescence
imaging. Immunophenotyping of peritoneal cells will be performed by flow cytometry. We anticipate that lectikines
will elicit significant efficacy through increased immune activation in the tumor microenvironment. Successful
completion of this pilot project will establish an initial proof-of-concept and generate a compelling data set for
further investigation and development of a first-in-class OVCA immunotherapy.

Public health relevance
NARRATIVE This project will generate novel immunotherapeutic drug candidates against ovarian cancer based on lectikines, which are recombinant fusion proteins consisting of the tumor glycobiomarker-targeting lectin Avaren and an antitumor cytokine. We will design and produce several lectikine constructs and evaluate them in in vitro assays and in a mouse ovarian cancer model. Successful completion of this pilot project will establish an important proof-of-concept data package justifying further preclinical development of our first-in-class immunotherapeutic candidate for ovarian cancer.